THE CONTRACTOR SHALL COMPLETE ALL SUBTASKS DESCRIBED IN THE SUBJECT CONTRACTS STATEMENT OF WORK FOR TASK 3, ACQUISITION, ANALYSIS, STORAGE, SHIPMENT O

The Contractor shall complete all subtasks described in the subject contract’s Statement of Work for Task 3, Acquisition, Analysis, Storage, & Shipment of Bulk Drugs, Other Chemical Compounds, and Drug Dosage Forms; Task 4, Acquisition, Analysis, Storage, & Shipment of Marijuana Cigarettes; and Task 5, Acquisition, Analysis, Testing, Storage, and Shipment of Nicotine Research Cigarettes.